Social Media Challenges and Adolescents: Who is at Risk and How Can We Prevent Injuries?

PROJECT SUMMARY
Social media (SM) use is ubiquitous among adolescents, and typical developmental factors during these
formative years put adolescents at exceptionally high risk for harmful effects from SM. Social media challenges
(SMC) (e.g., Tide Pod Challenge) are dangerous events where people engage in behaviors to share on SM
platforms while “challenging” others to participate. While media and peer-reviewed journals have described many
SMC and associated injuries, data on U.S. adolescents participating in SMC is scarce, including identified risk
factors or proposed elements for an intervention. Dr. Middelberg is a board-certified pediatric emergency
medicine pediatrician whose research focuses on pediatric injuries from consumer products to inform prevention.
This Mentored Patient-Oriented Research Career Development Award (K23) focused on understanding the
determinants and mitigators of SM risk-taking will allow Dr. Middelberg to gain additional skills to be a productive
clinician-scientist focusing on pediatric injury and prevention. She has built a strong mentorship team, including
national experts in pediatric injury, health behavior, decision psychology, and biostatistics. This team will provide
methodological and content expertise while guiding her Training and Career Goals to acquire needed skills to
be a successful independent investigator, which include gaining knowledge and proficiency in 1) study design
and statistical analysis, 2) using a health behavior framework to guide intervention development, and 3) elements
of injury prevention interventions specific to the adolescent age group. The rationale is that a better
understanding of adolescents participating in SMC, and how their behavior is similar or different from other risky
behavior, will add to evidence-based interventions and prevention measures for those irresponsibly using SM.
The specific aims are as follows: Aim 1: Determine predictive sociodemographic, SM use, and digital status
seeking characteristics, of adolescents who have participated in a SMC. Aim 2: Evaluate risk-taking behaviors
of an enrolled cohort of adolescents. Aim 3: Define key elements for a future intervention. The approach is a
prospective, cross-sectional survey study of adolescents (ages 13-21), followed by qualitative interviews, and
utilization of the health intervention planning framework, Intervention Mapping, to identify evidence-based
components of a proposed intervention. This award will provide Dr. Middelberg with the opportunity and training
to become an independent investigator with the goal of future applications for independent National Institutes of
Health funding.

Public health relevance
PROJECT NARRATIVE Social media challenges are often dangerous events where people share content of themselves engaging in risky behaviors and challenge others to do the same. Adolescents are particularly at risk for participation in social media challenges and harmful effects include injury and death, but few studies examine this population for necessary public health interventions. This proposal will be the first to identify risk factors for U.S. adolescent involvement in social media challenges, assess for concurrence of other high-risk behaviors, and identify evidence-based components for an effective intervention.